dMRI-guided pre-operative planning for supra-total resection of high-gradegliomas

ABSTRACT
High-grade gliomas (HGGs) are the most common primary brain malignancy in adults associated with very
poor survival rates despite various treatments. Surgery is the current mainstay treatment for HGGs, and the
main factor affecting survival rates (in over two decades) has been the increased extent of resection targeting
the “visible” contrast-enhancing tumor (CET) seen on conventional contrast-enhanced MR imaging. However,
since then research has shown that it is the “invisible” non-enhancing tumor (NET) which leads to progression
or recurrence in HGGs by infiltrating the surrounding white matter (WM) tracts. This has led to the adoption of
a supratotal resection (SpTR) approach, which includes resection of the `invisible' (microscopic) cancer beyond
the visible contrast enhanced margins. SpTR has been shown to result in better patient outcomes with
progression-free and overall survival. SpTR is undertaken using a combination of intra-operative techniques
but having a pre-op assessment of the functional anatomy will enhance the chances of preserving function and
maximizing tumor resection. Thus, the overarching goal of this Academia-Industry partnership (AIP) is to
provide a treatment planning tool that will facilitate safe SpTR maximizing the benefit of surgical therapy while
preserving neurologic function. The partnership builds on the technical expertise of UPenn for method
development, the translational expertise of Synaptive to integrate into a clinically deployable product, and
Mount Sinai's clinical expertise in evaluating it on patients. In Aim 1, UPenn will optimize and evaluate a
tracking paradigm that provides enhanced visualization of WM fibers in NET. This will entail by combining
tissue modeling, fiber tracking and tract delineation in clinically feasible multishell dMRI and optimize the
paradigm for reproducibility and generalizability across patients and acquisitions. A comprehensive comparison
of the approach to research and clinical paradigm will also be undertaken using retrospective data. The
prototype for this tractography paradigm will be integrated into the Synaptive neuro-navigation product
incorporating clinical and regulatory needs, with rigorous testing. The design will be optimized to maximize
clinical utility assessed through a multi-surgeon evaluation across different Synaptive sites. This will culminate
in the creation of an enhanced planning tool. Finally, in Aim 3, a prospective pilot study will be undertaken to
evaluate this tool on clinical efficacy for safe SpTR, with patients being longitudinally assessed for neurological
deficits. At the end of this study, the extensive evaluations will position the tool to a point of readiness for FDA
submission. The AIP will lead to an enhanced pre-operative planning tool to plan safe SpTR, complementing
intra-operative functional mapping, fulfilling a crucial unmet clinical need. The extended resection that this tool
will facilitate, will potentially lead to extended survival times and hence improve patient outcomes. Thus, this
tool is expected to significantly impact the clinical management of brain cancer, by affecting surgical treatment.

Public health relevance
PROJECT NARRATIVE This is an Academic-Industrial partnership proposal to provide an enhanced pre-operative planning tool for brain tumor surgery, that will facilitate extended safe resection of infiltrative tumors that are not evident in conventional imaging. The tool will be created by integrating diffusion MRI based methods developed by the academic partner to visualize white matter pathways in edematous and infiltrated regions, into the commercial neuro planning and navigational software of the industry partner and evaluated by the clinical partners for clinical utility and patient safety. The extended resection facilitated by the enhanced tool is expected to lead to better patient outcomes.